Effects of endogenous and exogenous ovarian hormones on Electronic Nicotine Delivery Systems (ENDS) Use

ABSTRACT
In 2018 the U.S. Surgeon General declared Electronic Nicotine Delivery Systems (ENDS) use a youth
epidemic. ENDS use continues to soar, especially among young adults (ages 18-24) who use more than any
other cohort. ENDS use is associated with negative cardiovascular, immunologic, and neurodevelopmental
illness. Young women are disproportionately impacted by ENDS use, due to more nicotine withdrawal
symptoms, greater cue induced cravings, and poorer treatment response. Yet, little is known about factors that
can inform sex-specific ENDS treatments. Variation in exposure to ovarian hormones either endogenously via
the menstrual cycle or exogenously via oral contraceptives may be critical sex-specific factors impacting ENDS
use. There is a dearth of studies focused on ENDS; however, burgeoning animal and human research on
combustible cigarettes suggests that there may be three pathways linking ovarian hormones to nicotine use.
Endogenous estradiol and progesterone are ovarian hormones that fluctuate across the menstrual cycle.
Based on the positive reinforcement pathway naturally occurring increases in estradiol paired with decreases
in progesterone during the follicular phase enhance the rewarding effects of nicotine leading to use. Based on
the negative reinforcement pathway we expect that individuals who experience affective reactivity in response
to naturally occurring drops in estradiol and progesterone during the luteal phase use nicotine to cope with
distress. Lastly, ethinyl estradiol (a synthetic form of estrogen common in oral contraceptives) increases
nicotine metabolism (i.e., quicker elimination of nicotine) resulting in more use to “replenish” nicotine
concentrations. Despite promising studies supporting these three pathways, meta-analytic findings show that
several studies show no effects. This may be because most studies do not directly measure ovarian hormones
or include biomarkers of nicotine metabolism, rely on cross-sectional between-subject designs, and infer a
dichotomized menstrual cycle phase, rather than capture hormonal variation. This project will utilize a 35-day
experience-sampling methods protocol that prospectively tracks menstrual cycle day, oral contraceptive use,
ENDS use, perceived nicotine reward, and affect. Ovarian hormones and a ratio of trans 3'-Hydroxycotinine to
cotinine (an established biomarker of nicotine metabolism) will be assessed from dried blood spots. We will
recruit ENDS users with naturally occurring menstrual cycles (n=100) and those on combined-type oral
contraceptives (n=100). This project expands research on biological sex-specific mechanisms and will
generate data that can guide tailored interventions.

Public health relevance
PROJECT NARRATIVE Electronic Nicotine Delivery Systems (ENDS) are non-combustible nicotine products (such as e-cigarettes or vape pens) that have become the most common form of nicotine use by young adults in the U.S. This research will examine the role of ovarian hormones in predicting use patterns of ENDS. This project expands research on biological sex-specific mechanisms and will generate data that can guide tailored interventions.